Multisite phosphorylated S6K1 directs a regulatory module determining adipocyte lipid metabolism

Project Summary/Abstract
Obesity is an epidemic-scale problem in the U.S. and worldwide with enormous health and economic costs. The
mTORC1-S6 kinase 1 (S6K1) axis drives anabolic pathways determining obesity. We recently identified
glutamyl-prolyl tRNA synthetase (EPRS) as an mTORC1-S6K1 target that contributes to mouse adiposity.
Insulin-stimulated EPRS phosphorylation at Ser999 by S6K1 in adipocytes induces its binding to fatty acid
transport protein 1 (FATP1) and translocation to the plasma membrane to increase long-chain fatty acid (LCFA)
uptake. Recent studies reveal that phosphorylation of S6K1 by cyclin-dependent kinase 5 (Cdk5) at Ser424 and
Ser429 in the S6K1 C-terminus are required for phosphorylation of EPRS, but not for canonical substrates such
as RPS6. This unexpected finding indicates that embedded in S6K1 is a target-selective phospho-code in which
combinatorial phospho-site phosphorylation determines kinase targets. To identify additional targets of multi-phosphorylated
S6K1 (termed S6K1*) but not mTORC1-activated S6K1, we transfected HEK cells with S6K1
bearing phospho-mimetic mutations at the 3 phospho-sites, or wild-type S6K1 cDNA. Three new S6K1* targets
were identified by mass spectrometry and validated in adipocytes – coenzyme A synthase (COASY), cortactin,
and lipocalin 2. Importantly, all are implicated in adipocyte lipid metabolism: P-EPRS transports FATP1 to the
plasma membrane for increased LCFA uptake; COASY catalyzes the final two steps of synthesis of coenzyme
A, required for LCFA activation; lipocalin 2 increases LCFA β-oxidation and insulin resistance; and cortactin is
required for insulin-stimulated transport of Glut4-containing vesicles to plasma membranes. We propose that
S6K1* directs an adipocyte lipid metabolon, and is a major contributor to obesity-related phenotypes driven by
the mTORC1-S6K1 axis. We will test this hypothesis by pursuit of 3 Specific Aims: In Aim 1 we determine
S6K1*/target docking domains. By mass spectrometry and site-directed mutation analysis, we will determine
specific S6K1*-directed phosphorylation sites in the targets. In Aim 2 we determine the function of
phosphorylated S6K1* targets in adipocyte lipid metabolism. We will determine the mechanism of insulin-stimulated
transport and binding of P-EPRS to the adipocyte plasma membrane; the role of phosphorylation in
COASY catalytic activity and localization; whether P-cortactin transports P-EPRS/FATP1-containing vesicles to
the plasma membrane; and extracellular secretion and intracellular localization of P-lipocalin 2, and its role in
LCFA oxidation. In Aim 3 we elucidate In vivo role of S6K1* in lipid metabolism and obesity. We will determine
the effect of diet-induced obesity on the S6K1* activation pathway and on target phosphorylation in mice.
Taking advantage of our new mouse model (generated by Crispr-Cas9 technology) bearing a Ser429-to-Ala
mutation in Rps6kb1 (mouse gene encoding S6K1) that lack S6K1* activity, while retaining canonical S6K1
activity, we will test the role of S6K1* in target phosphorylation in vivo, in lipid metabolism, and in diet-induced
obesity.

Public health relevance
Project Narrative Obesity is a worldwide, epidemic-scale problem with enormous health and economic costs. We have discovered a new signaling pathway that directs fat accumulation in adipocytes (fat cells). We will investigate the role of this pathway in fat synthesis in adipose tissue in mice, and anticipate insights that will permit development of new therapeutic targets and new drugs against obesity in humans.